Gut permeability and variations in bio-available vitamin D as mechanisms of adverse cognitive development in HIV-affected & control children - Anested Pilot Study

Vitamin D deficiency (VDD) is common in the general population, especially among
people living in higher altitudes or areas with limited sunshine as well as persons living with HIV
(PLWH). VDD impacts the gut microbiome and disturbances along the gut-brain microbiota axis
may influence the central nervous system (CNS) homeostasis, alter innate and adaptive
immune systems, and increase intestinal permeability and microbial translocation making the
gut and blood-brain barriers leaky. VDD is also associated with higher prevalence of
developmental disorders like autism spectrum disorder (ASD), attention deficit and hyperactivity
disorder (ADHD), and poor socio-emotional adjustment in children. Studies among cART
treated persons suggest ART further dysregulates vitamin D metabolome in potentially regimen
dependent fashion. For children HIV exposed but uninfected, whether peripartum-ART
exposure during sensitive developmental windows results in long-lasting changes in the
metabolome of vitamin D with consequence for gut microbial profile and neurodevelopmental
trajectory remains unknown.
Our ongoing RO1 study aims to develop a Cognitive Risk Index (CRI) by combining data on
nutrition, immune parameters and HIV status and their interactions to validate CRI as a
predictor of neurocognitive disorders at 12 months. In this pilot study we collect preliminary
data for future definitive investigations and inform existing knowledge gap by investigating HIV
status and early ART exposure related dysregulations in vitamin D metabolome and gut-
microbial dysbiosis as modifiable mechanisms of adverse cognitive development and
developmental disorder risk in vulnerable children. Specific aims include: To
a) Assess vitamin D metabolites using a metabolomic approach to quantify relative abundance
of bioactive forms of the respective Vitamin-D canonical forms (D2, D3).
b) Assess biomarkers of intestinal permeability and its relationship with VDD, and HIV status.
c) Clinically evaluate and diagnose 100 children selected per baseline disorder probability
scores estimated per the Behavioral Assessment System for Children, Third Edition
(BASC3) and the social Responsiveness Scale, Second Edition.
Overall Impact: This data will provide preliminary data that serves as proof of concept to further
establish the scientific rationale for a more definitive mechanistic study of variations in the
metabolome of vitamin D and gut-microbial dysbiosis as modifiable determinants of adverse
neurodevelopment among Ugandan HIV-affected and control children.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Vitamin D deficiency (VDD) is common, but especially higher among persons living with HIV. Although underlying mechanisms of impact are not fully elucidated, variations in vitamin D metabolome and VDD contribute to increased gut microbial dysbiosis, cognitive problems and potentially developmental disorders. This pilot investigation is designed to contribute to this information gap by providing preliminary data with respect to HIV group differences in the prevalence of various neurodevelopmental disorders, biomarkers of gut microbial dysbiosis and metabolites of vitamin D in a sub-sample of children already being followed in the NINDS supported parent grant (NIH R01NS122510).